Animal care: supporting research on pathogenesis and treatment of autoimmunity

The LACU assists the NIAMS IRP investigators with their research involving animals. Such animals are housed in shared animal facilities on the NIH campus including the NIAMS LACU directly overseen facility located in Building 10 in 9/C127 in the ACRF Buildings 6B, 10A, 50 and the Building 14 complex. NIAMS animal users work primarily with mice and rats. The NIAMS IRP Animal Program has oversight for 20 Animal Study Proposals (ASPs) using mouse and rat models. The LACU assists researchers prepare ASPs and has 2 voting members and 1 alternate on the NIAMS Animal Care and Use Committee (ACUC). The LACU mainatins the foster colony and the sentinel program for the IRP. IRP Projects include arthritis, allergic rhinitis and other transmit receptor-induced cellular responses, recombination/chromatin remodeling using AID transgenic mice, familial Mediterranean fever (FMF), and TNF receptor associated periodic syndrome. Research involves muscle and related diseases (experimentation with: N-RAP protein, glycogen storage disease Type II, SIRT1 gene, myofibril assembly, and myositis) and sub-cellular organelles and cytoskeleton in skeletal muscle as well as in vitro experiments examining retroviral transduction, bone marrow transplantation, and epidermal differentiation using fetal and adult skin tissues. Many of the institutes studies involve apoptosis and autoimmunity, as well as cartilage studies focused on tissue-engineered cartilage, chondrogenesis, GDF-F, COMP and osteoarthritis. The 10/9C127 Animal Facility was renovated to add approximately 900 mouse cages to the existing facility. The LACU successfully transferred approximately 70 mouse lines from Germantown, New York to Bethesda, Maryland in a period of two and one half months during the summer of 2012.